ARGININE METABOLISM IN YOUNG HUMAN ADULTS--ACUTE CHANGES OF ARGININE INTAKE

This study will develop a new, multiple stable isotope tracer model body arginine and ornithine metabolism in intact, healthy adult human subjects; determine whether arginine synthesis is affected by absence of dietary arginine; and provide a database for studies of the affects of major burn trauma on arginine metabolism.